PHASE I/II STUDY OF HIVIG IN SLOWING PROGRESS OF DISEASE IN HIV INFECTED CHILD

This study will test the hypothesis that human immunodeficiency virus globulin IV (HIVIG) will decrease the viral burden of moderately advanced HIV-positive children.